GENETICS OF VEGF MEDIATED ANGIOGENESIS IN MOUSE SKIN

[unreadable] DESCRIPTION (provided by applicant): Angiogenesis is essential for normal embryonic development, wound healing, and postischemic tissue repair. However, angiogenesis is also associated with pathological conditions like diabetes, psoriasis, and cancer. The Vascular Endothelial Growth Factors (VEGF) are a family of secreted glycoproteins that control angiogenesis. Recent studies have shown that different strains of inbred mice have a 10-fold range of response to VEGF-induced angiogenesis. Thus, unknown genetic factors must control VEGF responsiveness in mice. The discovery of the genes behind these differences could lead to new angiogenic therapies. We have developed a novel quantitative ex-vivo skin biopsy method to evaluate angiogenic response in the skin of mice. Our method is unique for the following reasons: First, the microvasculature of the skin is well-suited for angiogenic response because it is a primary site of neovascularization in wounding and the skin is a common site of tumor formation. Second, our skin-based approach is performed on multiple samples per individual, decreasing the potential for environmental variation. Finally, because our method is performed on euthanized three-day-old mice, we can perform mapping crosses in an efficient manner. Our preliminary findings have shown that FVB/NJ mice produced the highest amount of blood vessels in our skin biopsy model when compared to C57BL/6J mice. The VEGF hypersensitivity in FVB mice is a recessive trait and based on our preliminary data is likely to be controlled by fewer QTLs than previous approaches designed to map angiogenesis QTLs in mice. We propose to map the QTLs responsible for the novel difference in FVB/NJ skin and define the biological basis of these differences. This work is vital to human health because several therapies designed to control angiogenesis in human disorders are currently in clinical trials based in part on data obtained from mouse models. Our results will improve the validity of testing of mouse models and could lead to the discovery of new therapeutic targets or biomarkers for VEGF mediated therapies. [unreadable] [unreadable] [unreadable]